MINERAL SUPPLEMENTATION IN PRETERM INFANTS WITH BRONCHOPULMONARY DYSPLASIA

Effect of calcium and phosphorous supplementation on the development of nephrocalcinosis in preterm infants with bronchopulmonary dysplasia.